Core A - Administrative Program Enrichment Core

Project Summary – Administrative Program Enrichment Core
The UAB Nathan Shock Center (NSC) has as its research focus the comprehensive assessment of energy
intake and use from the level of organelles, cells, and tissues (Comparative Mitochondrial Health Assessment
Core) to whole organisms (Comparative Organismal Energetics Core) as it relates to aging and later-life health
in a diversity of species. Findings at these various levels are analyzed and integrated by our Comparative Data
Analytics Core. Comparative energetics is a cornerstone of what has come to be called “geroscience,” the
study of interactions between fundamental aging processes and maladies of later life. The Administrative
Program Enrichment Core (Admin Core) is the oversight, administrative, and outreach arm of the UAB NSC as
a whole. Under the leadership of Drs. Steven Austad and Thomas Buford, the Admin Core will continue to
manage, coordinate, publicize, and integrate the diverse activities of the Center. It also will be responsible for
facilitating interactions with the other Shock Centers, the Nathan Shock Centers Coordinating Center, and
relevant National Institute on Aging (NIA) staff. In consultation with the Internal and External Advisory
Committees, the Admin Core will issue annual evaluations and reports on each Core's performance and on the
performance of the NSC overall and will make programmatic changes as warranted. This Core also will be the
organizational unit responsible for promoting basic aging research at UAB, regionally, and nationally, seeking
particularly to attract trainees and early career researchers from allied disciplines into geroscience research.